Saccade Target Selection in Naturalistic Visual Search

Project Summary
Understanding how we select targets for saccadic eye movements is a basic research question of far-reaching
importance. These rapid eye movements allow the fovea to fixate objects of interest, and we typically make
more than 170,000 saccades each day. Saccades are essential for efficient visual perception and action: from
reading to cooking to driving, most common behaviors heavily engage the saccadic system, and a
dysfunctional mechanism for selecting saccade targets would impair performance in all of these everyday
activities. The superior colliculus (SC), a key midbrain structure responsible for controlling saccades, is
comprised of two subdivisions: the superficial layers (SCs), which respond predominantly to visual stimuli, and
the intermediate layers (SCi), which can show both visual and saccade-related responses. Despite its
importance, we still know little about how the SC selects saccade targets in realistic conditions. This study will
address this critical gap in our knowledge. A major obstacle to progress in this area has been the complexity of
analyzing neural responses under naturalistic conditions, and tackling this problem requires a model that can
provide testable predictions of neural responses in naturalistic conditions. We will use a state-of-the-art neural
model, MASC (Model of Attention in the Superior Colliculus), which incorporates constraints based on SC
anatomy and physiology, and does a superior job of predicting saccade endpoints and scanpaths in a variety
of search and free-viewing tasks. In conjunction with neural recordings, we will elucidate how superficial- and
intermediate-layer SC neurons differ in their integration of activity related to salience, relevance, inhibitory
tagging, and movement selection during multi-saccade visual search. In addition, we will test the contributions
of the frontal eye field, a cortical area providing input to the SC, to these search-related signals in the SC.

Public health relevance
Project Narrative Accurate and efficient saccadic eye movements are essential for performing most visuo-motor tasks, including things like reading, cooking, and driving, and a dysfunctional mechanism for selecting saccade targets would impair all of these everyday activities. These experiments will help to reveal the architecture of the saccadic eye movement system, leading to a better understanding of human neurological syndromes which disrupt eye movements, including hemi-spatial neglect and attention deficit hyperactivity disorder (ADHD).